Sorting high extracellular vesicle secretors for optimal cell therapy

PROJECT SUMMARY
Stem cell therapies are gaining traction in the treatment of ischemic diseases such as myocardial infarction.
Among these, mesenchymal stem cells (MSCs) have emerged as a promising treatment avenue. Extracellular
vesicles (EVs) released from MSCs play pivotal roles in driving regenerative cell therapies. However, notable
discrepancies exist in the EV secretion capabilities among MSCs, leading to inconsistencies in therapeutic
outcomes. To optimize cell therapies, it is critical to sort out and enrich cells based on EV secretion amount and
type. However, current cell sorting techniques, focus solely on cell surface markers and do not address
secretions like EVs. Consequently, there is an urgent need to develop a technology to enrich millions of single
cells based on their EV-secreting capacity, thus enhancing the efficacy of stem cell therapy. Here, we introduce
a technology called "nanovials," designed to sort millions of cells based on their EV secretion levels using
tetraspanin molecular markers. We hypothesize that this technology can enrich populations of MSC with
inheritable high EV-secreting ability that leads to higher therapeutic efficacy. This platform also helps to uncover
crucial insights into EV biogenesis and secretion pathways through integration with single-cell transcriptomic
analysis. The overarching goal of this R01 is to optimize the methods to enrich EV-secreting MSCs and test the
efficacy of subpopulations of high- and low-EV secreting cells in small and large animal models of myocardial
infarction. AIM 1: Fabricate Nanovials and optimize EV-secreting cell sorting methods. AIM 2: Comprehensive
characterization of the high EV-secreting MSCs. AIM 3: Determine therapeutic effects of high EV-secreting
MSCs in a clinically relevant porcine model of myocardial infarction. We have developed a platform to isolate
cells with enhanced EV secretion capabilities. This innovation has the potential to mitigate the issues linked to
EV secretion variability and batch discrepancies present in existing cell therapies. Moreover, leveraging
transcriptomic analysis enables us to categorize cells based on their propensity for EV secretion. This refined
categorization aids in discerning which subset of stem cells yield superior therapeutic results, thereby guiding
our efforts to engineer quantitatively repeatable cell therapies.

Public health relevance
PROJECT NARRATIVE Heart disease is the leading cause of death in the United States and about 875,000 Americans die from heart disease each year, of which 50-60% deaths are caused by coronary artery disease which can further develop into heart failure and scarring. Mesenchymal stem cells hold the potential to repair the injured cardiac muscle after a damage takes place. Here, we plan to develop and test a technology to sort out the most potent mesenchymal stem cells by the extent of exosome secretion.